"Project 2" Microprocessor overload in gamma-herpesviral oncogenesis

Summary
The Epstein Barr virus (EBV) is a causal agent in Hodgkin’s lymphoma, non-Hodgkin’s lymphoma, gastric
cancer, nasopharyngeal carcinoma and autoimmune diseases. In the context of HIV co-infection (+ or - ART),
EBV is especially problematic with a substantially elevated risk of EBV-associated lymphomas. The overall
objective of this P01 is to investigate the role of non-coding RNAs in HIV-associated malignancies. Our
assessment of EBV-associated Burkitt’s lymphoma (BL) and gastric cancer (GC) patient datasets revealed that
outside of the ubiquitously expressed small EBER1/2 non-coding viral RNAs, in vivo viral gene expression is
primarily limited to two overlapping long non-coding RNAs, A73 and RPMS1 and two large miRNA clusters
contained within the RPMS1 introns. Strikingly, we found that viral miRNAs comprise up to 75% of all miRNAs
expressed in the cell in both BL and GC clinical samples. MiRNA targetome analyses revealed that EBV (and
KSHV (Project 1)) miRNAs interact more effectively with their targets than their cellular counterparts, in part
through targeting more accessible regions of RNAs and through forming hybrids with more favorable binding
energies. Functionally, we found that EBV miRNAs likely suppress innate and adaptive immune responses to
viral infection. Together, these studies support the contention that EBV miRNAs are key contributors to the
tumor phenotype in EBV associated lymphomas.
Although certain cell miRNAs are known oncogenes, there is extensive evidence for a generalized lower
expression of cell miRNAs in cancer. Further, driver mutations in miRNA processing genes have been
identified in a number of cancer types. Utilizing patient RNA-seq data, we found that cell miRNA processing is
diminished in EBV positive tumors and we show that expression of EBV miRNA clusters in EBV negative cells
causes decreased processing of endogenous cell miRNAs. We hypothesize that the introduction of multiple
copies of ectopic high-density miRNA clusters into cells upon EBV infection not only yields high viral miRNA
production but also causes sequestration of microprocessor resources and inhibited processing of cell
miRNAs. We further hypothesize that viral microprocessor inhibition diminishes the expression of cell tumor
suppressor miRNAs to influence the tumor phenotype in a manner similar to genetic alterations of miRNA
processing factor genes.
In this proposal, we will use bench work, viral recombineering (Core C), and bioinformatics (Core B) in tissue
culture, animal models (Core D), and clinical models to 1) determine the functional impact of direct viral miRNA
targeting on immune regulatory pathways and 2) delineate the underlying mechanisms, the impacted
oncogenic pathways, and the functional consequence of EBV-mediated microprocessor overload on the tumor
phenotype. We will also begin preliminary studies to determine whether microprocessor overload is a shared
feature extending to other oncogenic herpesviruses through testing the KSHV (Project 1) miRNA cluster.

Public health relevance
Project narrative The Epstein Barr virus (EBV) is a primary causative agent in HIV-associated lymphomas. Based on preliminary studies in tissue culture and clinical models, we hypothesize that two large EBV miRNA clusters are critical players in eliciting the tumor phenotype through altering the immune cell microenvironment via their canonical functions and cell growth and/or protection against cell death through a previously unknown non-canonical mechanism.